James A Haley Veterans' Hospital’s Summer Tampa Research Immersion Program or "Summer TRIP

The Summer Tampa Research Immersion Program (Summer TRIP) at the James A Haley Veterans’
Hospital is an interdepartmental collaboration between Research and Development, Physical Medicine
and Rehabilitation, and Mental Health and Behavioral Sciences. The long-term goal of this program is
to grow the next generation of VA health sciences researchers by targeting students early in their
academic careers. The specific aims of this study are to: (1) Recruit and retain a diverse cohort into VA
research careers; (2) Foster research knowledge and skill development; and (3) Conduct program
evaluation to improve this program. This 5-year program will recruit 6 to 23 students at various
academic levels (e.g., high school students, undergraduate students, medical students) per annual
cycle. Students from underprivileged and underrepresented groups will be targeted via existing and
emerging relationships with local high schools, community colleges, and universities. Recruited
students will participant in a 12-week intensive research education and training program, consisting of a
major research experience (3 days/week), a minor research experience (1 day/week) and research
education and professional development didactics (1 day/week). Didactics will include research ethics
and responsible conduct of research. Research experiences will focus on in-lab (basic and clinical)
research from a team of mentors whose research focuses on the polytrauma triad (i.e., traumatic brain
injury, chronic pain, posttraumatic stress disorder), spanning bench, human subjects, and
implementation research. Recruited students (i.e., mentees) and mentors will be evaluated on their
progress toward learning goals multiple times over the 12-week cycle. Mentees will gain scientific
conference exposure by attending an in-house annual Polytrauma Research Exposition which occurs
annually at the site’s hospital; as well, mentees will present research findings at an in-house Summer
TRIP Research Symposium, developed specifically for this program, and will take place annually at the
hospital’s Polytrauma Rehabilitation Center’s public space. As well, five committees (executive,
mentorship, education, evaluation, and the community engagement council with external advisors) will
guide program development, program evaluation, and program improvement across the five years of
this study. The study multiple principal investigators (MPIs) will co-chair the executive committee, which
will also include chairs of the other committees (other program faculty) to enhance information transfer
across committees. The Summer TRIP program faculty include the two study MPIs, 11 faculty mentors
(VA researchers), plus other stakeholder and advisors. Short and long-term outcomes (multi-method) of
the program include assessment of student (mentee) perception of knowledge and skill gained during
the program, mentor perception of mentee knowledge and skill development, evaluation of didactics,
mentee research productivity, mentee retainment in health sciences education and careers, and
evaluation of success toward recruitment and retention targets, including diversity factors. A manuscript
detailing the development of the Summer TRIP program and the evaluation of the program will be
drafted and submitted to a scientific journal that publishes studies on health care education and
program development and evaluation. As well, information about the development and execution of this
program will be shared nationally, for example, during the regularly scheduled VA Polytrauma System
of Care teleconference (quarterly meeting).

Public health relevance
Health care management the polytrauma triad of traumatic brain injury, posttraumatic stress disorder, and chronic pain remains a health care priority within the Department of Veterans Affairs. Although treatment programs are in place within the VA Polytrauma System of Care, bench-to-bedside translation gaps continue to hinder transition of research findings into clinical practice. A skilled and diverse workforce that fosters collaboration across various branches of science is needed to accelerate progress in developing new and more effective treatments for Veterans with traumatic brain injury, posttraumatic stress disorder, and chronic pain. This proposed Tampa Research Immersion Program (Summer TRIP) program, at a tertiary teaching VA hospital and flagship Polytrauma Rehabilitation Center, will provide research translation training for students from underrepresented backgrounds to foster the future generation of a diverse workforce of VA health scientists.